Expanding regional capacity for single molecule sequencing through the purchase of the Sequel IIe sequencing system

PROJECT SUMMARY
The University of Louisville’s Sequencing Technology Center (STC) is requesting support to acquire a Pacific
Biosciences Sequel IIe sequencing system. The requested system would be the second Sequel IIe system in
the Center, as demand from the diverse STC user base, comprised of regional, national, and international
extramurally funded investigators has far exceeded the capacity of our initial, single instrument. Since launching
in 2021, the STC has assisted in the planning, preparation, and execution of many projects leveraging the power
of long read, single molecule, real-time (SMRT) sequencing for projects that use both standard high fidelity (HiFi)
workflows, and those that involve development of custom, innovative targeted methods to elucidate complex
genomic loci or communities with phased, highly accurate long reads. Unlike other sequencing systems on the
market, the Sequel IIe system has the combination of long read capabilities (150 bp – 100 kb) and the highest
accuracy available from any NGS- and single molecule-sequencing instrument (ranging from Q30, 99.9% - to
Q60, 99.9999%, across our projects), both of which are critical for meeting the needs of our Major, Minor, and
service users. The STC is well established and already has the infrastructure and operational capabilities to
implement this requested second Sequel IIe system, which is absolutely necessary for meeting the needs of our
growing user base, Major User research projects, and further genomics methods development using the power
of SMRT sequencing technology. The University of Louisville, particularly the Office of Research and Innovation,
is dedicated to supporting the requested system through financial and infrastructure investment into the STC.
From the generation of new reference genomes to targeted characterization of viral reservoirs and immune loci,
and critically important SARS-CoV-2 pathogen surveillance across the Commonwealth of Kentucky, the STC
facility has and will use its expertise with SMRT sequencing and the proposed new Sequel IIe system to work
closely with local and national experts to facilitate cutting-edge genomics projects across a wide variety of
research areas with the major goal of promoting and inspiring research and innovation in support of the growth
of the research enterprise at the University of Louisville.

Public health relevance
PROJECT NARRATIVE High fidelity (HiFi) reads generated with single molecule, real time (SMRT) sequencing are the foundational data type needed to generate highly accurate, contiguous whole genome de novo assemblies, and are incredibly powerful when used in a targeted fashion to unambiguously resolve haplotype-phased complex genomic loci. As nucleic acid sequencing technologies continue to develop and improve, we have the responsibility and need to provide investigators with the state-of-the-art tools required to perform cutting-edge genomics research in a timely and cost-effective manner. The goal of this proposal is to obtain support for the purchase of a second Pacific Biosciences Sequel IIe sequencing system for our Sequencing Technology Center, which will provide much needed additional bandwidth and throughput for funded NIH projects, significantly enhancing the biomedical research programs at University of Louisville and our regional and national collaborative partners.